Automating Scientific Knowledge Extraction and Modeling (ASKEM)

The objective of the Automating Scientific Knowledge Extraction and Modeling (ASKEM) Program is to create a knowledge-modeling-simulation ecosystem, empowered with Artificial Intelligence (AI) approaches and tools needed for the agile creation, sustainment, and enhancement of the complex models and simulators necessary to support expert knowledge- and data-informed decision making in diverse missions and scientific domains. The effectiveness of the tools will be demonstrated in applications relevant to viral epidemics such as COVID-19 and to the causes and impacts of space weather. ASKEM tools will enable experts to maintain, reuse, and adapt large collections of heterogeneous data, knowledge and models – with traceability across knowledge sources, model assumptions, and model fitness.